Inference by interference: Task-dependent pupil responses as an early detection method for Alzheimer's disease related brainstem functional change

ABSTRACT
Trials aimed at changing the hallmark proteinopathies of Alzheimer Disease (AD), Aβ and tau, have been
disappointing in halting or reducing cognitive decline. As these trials are often performed in symptomatic
individuals, where brain changes are irreversible, shifting interventions to asymptomatic individuals may be
more effective. The conundrum is to identify people who are more likely to be at risk of AD and who will benefit
from these interventions. While Aβ starts in the neocortex about 15 years before clinical symptoms, tau pathology
starts to accumulate from age 20 in the locus coeruleus (LC) before propagating towards the transenthorhinal
cortex, the limbic system and subsequently to the cortical regions. However, it is important to note that even
though by age 50, tau is omnipresent in the LC, not everyone will develop AD. Given that accumulation of tau in
the LC is associated with loss of projections, we posit that functional measures of the LC-Norepinephrine system
(LC-NE) may be more sensitive to distinguish individuals at-risk from those who are likely to maintain cognitive
health. The LC-NE system plays an important modulatory role in behavioral and cognitive processes including
‘executive’ functions like attention and working memory. The overall goal of the proposed project is to
detect the earliest AD related changes through read-outs related to LC function, which will
ultimately contribute to improved identification of the target population for interventions and
increase the efficacy of these interventions. LC neuronal function is characterized by tonic (that we can
elicit by increasing CO2) and phasic firing patterns (that can be elicited by novelty). Changes in pupil dilation
receive contributions from the LC-NE system, and by providing specific cognitive task loads, phasic and tonic LC
function can be derived. Wehypothesize that the pupil response in a task reacting to new tones after
a short breath hold vs no breath hold can be a biomarker of very early AD-related processes. We
will test these hypotheses in a group of clinically normal individuals (age range 55-80 years, n=70, 50% female)
leveraging to an ongoing deeply phenotyped cohort (SerialMK) that already collects Aβ and tau-PET imaging.
The results of this proposed project will contribute to improved detection of individuals at-risk by determining
(Aim 1): To investigate the tonic-phasic balance in pupil responses in different task settings (oddball, and oddball
after breath hold) and their relation to age and sex. (Aim 2): Relating pupillary responses in these different task
settings to AD pathology. The proposed research is innovative as it aims to identify at-risk populations in a non-
invasive, functionally relevant manner, using a readout of one of the earliest affected brain systems and thereby
opening up the opportunity to benefit prevention trials at a time in life when pathology is not yet extensive.

Public health relevance
NARRATIVE Even though the locus coeruleus, a small region in the brainstem, is one of the first sites where pathologic tau proteins are found in early midlife, not everyone heads down an irreversible Alzheimer’s disease trajectory. The proposed study aims to measure pupil dilation during different tasks as a proxy of locus coeruleus function with the ultimate goal to differentiate individuals at-risk for Alzheimer’s disease from those who will age successfully. This project has important public health implications and is relevant for the NIH’s mission as it will provide insight in the selective vulnerability of the locus coeruleus in Alzheimer’s disease, enable early detection in an easy non-invasive manner, and improve the inclusion criteria to make future preventative treatments more effective.